Planning for Implementation of a Family-based Intervention for Prevention of HIV, Substance Use, and Mental Health Problems among Hispanic Youth at Risk: A Community-Engaged Approach

Hispanic youth at risk face disparities in HIV, substance use, and mental health non-Hispanic peers. Family-based interventions are effective in preventing and reducing HIV acquisition, substance use, and mental health
concerns. Our team developed Familias con Orgullo (“Families with Pride”), a family-based intervention to
prevent HIV, substance use, and mental health problems among Hispanic youth at risk. Despite the promise of
Familias con Orgullo, there are anticipatable challenges to implementing Familias con Orgullo in community
settings given commonly cited barriers such as inadequate time and resources by staff. However, it is unclear
what specific implementation strategies would facilitate adoption and implementation of Familias con Orgullo.
The purpose of the proposed study is to co-design an implementation strategy package iteratively in collaboration
with community agencies across Miami-Dade County using a systematic implementer-driven method to inform
the future adoption and implementation of Familias con Orgullo. The aims of the study are: AIM 1: identify
determinants affecting adoption and implementation of behavioral HIV prevention interventions, such as Familias
con Orgullo, in community agencies, AIM 2: iteratively co-design an implementation strategy package to support
community agencies in adopting and implementing Familias con Orgullo, and AIM 3: evaluate the relative
priority, acceptability, appropriateness, and feasibility of the implementation strategy package for promoting
adoption and implementation of Familias con Orgullo. The proposed research aims complement my training
goals to: Training Goal 1: develop advanced skills in implementation science for prevention of HIV, substance
use, and mental health problems among Hispanic youth at risk, Training Goal 2: develop expertise in
community-engaged methods to develop implementation strategies and conduct implementation research,
Training Goal 3: build skills in syndemic theory to address HIV, substance use, and mental health problems,
and Training Goal 4: expand my professional development training. Successful completion of these aims will
enable me, as part of a future R01, to test the impact of developed implementation strategies on adoption and
implementation of Familias con Orgullo in community settings in addition to evaluating the effectiveness of
Familias con Orgullo. My long-term goal is to become an independent researcher focused on using
implementation science to mitigate HIV, substance use, and mental health disparities among Hispanic youth at
risk. With a mentorship of a team of interdisciplinary researchers, experts in implementation science,
implementation research methodology, behavioral HIV-prevention, and family-based interventions, I will
successfully complete the planned research and training aims proposed in this career development award at the
University of Miami, resulting in a solid foundation for me to launch my career as an independent researcher.

Public health relevance
This study will iteratively develop an implementation strategy package in collaboration with community agencies across Miami-Dade County using a systematic implementer-driven method to inform the future adoption and implementation of a family-based intervention for Hispanic youth at risk, Familias con Orgullo (“Families with Pride”). The knowledge expected to be gained from this study has the potential to accelerate the standard model of translating research into practice. Understanding implementation determinants related to Familias con Orgullo and thus accelerating implementation via earlier development of implementation strategies is central to achieving the goals of the Ending the HIV Epidemic Initiative and reducing syndemic HIV, substance use, and mental health disparities among Hispanic youth at risk.